Cryptoprotective Autophagy in Bone Metastatic Prostate Cancer

Project Summary/Abstract Candidate: My immediate career goals are to obtain the necessary training and skill set required to be competitive for a tenured faculty position and to accumulate data sufficient for an R01 or similar funding mechanism. My long term career goals are to be a tenured, funded cancer biology professor, a mentor, and a science administrator. To this end, the key elements of my career plan are focused on 1) developing my independent research, 2) continuing my technical and research administrative education, 3) honing my communication skills, and 4) gaining more mentoring experience. Environment: I can successfully meet my goals because I have access to state-of-the-art equipment, core facilities, and educational resources at Rice University, the Texas Medical Center, and through a prostate cancer P01 collaboration that includes the University of Delaware, Emory University, and Cedars-Sinai. I also have a team of phenomenal mentors who are leaders in the prostate cancer and cancer health disparities fields. These mentors include my primary mentor, Dr. Mary Farach-Carson, co-mentor, Dr. Leland Chung, and Drs. Nora Navone and Lovell Jones, who have each agreed to provide me with career development guidance. Research: Prostate cancer (PCa) is the second leading cause of death in North American men, where 80% of PCa mortality is due to bone metastasis. PCa tumors can contain neuronal-like neuroendocrine (NE) PCa cells, which correlates with poor prognosis. NE PCa cells are resistant to apoptosis, secrete proteins to induce cell proliferation and angiogenesis, and can de-differentiate to contribute to tumor growth. Our lab recently published data revealing that bone marrow stromal cell (BMSC) paracrine signaling induces apoptosis in co-cultured bone metastatic PCa cells. However, a subpopulation of the bone metastatic PCa cells can avoid cell death and undergo neuroendocrine differentiation (NED). One process that has been shown to mediate cancer cell survival and cell differentiation is autophagy, the homeostatic process of intracellular degradation and recycling. Thus, I propose that autophagy is a cytoprotective mechanism that PCa cells use to survive and undergo NED in the bone marrow stromal microenvironment. To address my hypothesis, I will (1) dissect autophagy regulation in PCa cells exposed to BMSC, (2) demonstrate that autophagy enhances PCa cell survival and promotes NED, and (3) show that autophagy attenuation increases PCa cell death. Autophagy induction and function will be analyzed using immuno-blot and -staining for autophagy markers, such as LC3, and using acidic vesicle dyes, such as monodansylcadaverin. PCa cells will be subjected to genetic and pharmacological autophagy modulation and assayed for cell viability and the NED phenotype. My investigation will identify pathways to attenuate autophagy and redirect bone metastatic PCa cells towards cell death.

Public health relevance
Project Narrative Prostate cancer (PCa) bone metastasis is responsible for 80% of PCa death. Therefore, it is imperative to understand the biology of bone metastatic PCa cells in the bone environment. Hence, the purpose of this project is to determine the role of autophagy, a homeostatic process, in bone metastatic PCa cell survival and to determine if inhibition of autophagy can kill bone metastatic PCa cells. __SpecificAimsTextDelimiter__ I. SPECIFIC AIMS: Autophagy is the process of sequestering cytoplasmic components for degradation and recycling. Autophagy has paradoxical cellular functions ¿ it can promote cell death or cell survival and can promote tumor suppression or tumor growth ¿ and thus, the physiological consequences of autophagy are context-specific. Autophagy promotes cell survival and tumor growth by relieving cellular metabolic stress that would otherwise activate apoptosis. Furthermore, autophagy provides a survival mechanism by which cancer cells can adapt to unfavorable growth conditions, such as at metastatic sites, and can withdraw from the cell cycle to become radiation and chemoresistant. Recently our lab published data revealing that bone marrow stromal cell (BMSC) paracrine signaling induces apoptosis in co-cultured prostate cancer (PCa) cells. However, a subpopulation of the PCa cells avoid apoptotic cell death and instead undergo neuroendocrine differentiation (NED), a process in which PCa cells phenocopy post-mitotic neuronal-like cells. Interestingly, autophagy has also been shown to mediate cell differentiation. Therefore, I propose a model in which, upon exposure to the hostile bone microenvironment, a subpopulation of metastatic PCa cells can hijack the BMSC paracrine factors to elicit an autophagic response sufficient to avoid apoptosis, survive metabolic stress, induce PCa NED, and maintain neuroendocrine (NE) PCa cell viability. To this end, I hypothesize that autophagy is a cytoprotective mechanism for PCa cells in the bone marrow stromal microenvironment. To address my hypothesis, I will perform the following specific aims: Specific Aim 1: Dissect the mechanistic regulation of autophagy in PCa cells exposed to BMSCs. Specific Aim 2: Demonstrate that autophagy enhances cell survival and promotes NED and viability of PCa cells exposed to BMSCs. Specific Aim 3: Provide proof-of-principal studies to show that autophagy attenuation in bone metastatic PCa cells is cytotoxic. By investigating my hypothesis, I will identify targetable signaling pathways to attenuate autophagy and redirect the bone metastatic PCa cells towards cell death.